REACH Center Exposure Assessment Core

PROJECT SUMMARY - EXPOSURE ASSESSMENT CORE
The REACH Center Exposure Assessment Core aims to provide expertise and services on big data use,
exposure assessment, and statistical analysis to support research exploring health and equity impacts of
climate solutions. The Core will develop unique, new services and capabilities in selecting and using
appropriate techniques and tools to assess exposure for a variety of climate-health research applications,
including epidemiology, risk analysis, burden of disease assessment, disease forecasting, future projections
under emission scenarios, policy analysis, and equity analysis. Datasets and tools will include satellite remote
sensing, ground stationary and mobile monitoring, statistical and geophysical modeling, among other
techniques. Specifically, the Core will build capacity among Center investigators to identify and select
appropriate geospatial climate and environmental datasets. To do so, the Core will empower researchers to
identify important climate-relevant hazards with screening-level mapping tools and aid researchers in selecting
fit-for-purpose geospatial climate and environmental datasets. The Core will also lower the barrier to using
geospatial climate and environmental datasets in research exploring health and equity impacts of climate
solutions. This will be accomplished by spatially and temporally aligning climate and environmental data with
health data, providing user guides with data descriptions and sample code, and providing consultation services
for researchers to ask questions about applying the datasets. Finally, the Core will provide statistical support,
including comprehensive statistical analysis, data usage advisory and consultancy, and conducting statistical
and collaborative research to advance beyond what is available in the current literature. The Exposure
Assessment Core will bridge the gap between novel geospatial datasets and research on health-protective and
equitable climate solutions by making geospatial climate and environmental datasets more accessible,
interoperable, and interpretable for health researchers. The Core enables the Center and the broader
community to overcome a major challenge in climate and health research: that climate and environmental data
are often spatiotemporally mis-aligned with health data, are poorly accessible to researchers outside of
geosciences, and come with various strengths, weaknesses, and uncertainties.